Transcriptional and epigenetic mechanisms of alveologenesis and re-alveologenesis

PROJECT SUMMARY
Lung diseases impacting the gas exchange alveoli, including COVID-19, are becoming the leading cause
of death. A multi-lineage, transcriptional, and epigenetic understanding of alveologenesis and re-
alveologenesis upon injury is a timely response to the disease burden and leverages latest single-cell
technology. My lab’s track record in studying the lung epithelial, endothelial, and mesenchymal lineages lays
the foundation for pursuing a poorly understood process of cellular maturation (Theme 1), a recently identified
capillary cell type (Theme 2), and a novel signaling regulation of distinct mesenchymal cell populations (Theme
3). The anticipated knowledge will tackle fundamental questions of cell fate, plasticity, and signaling; shed light
on bronchopulmonary dysplasia, pulmonary hypertension, acute lung injury, as well as non-coding variants
from genome-wide association studies; and opens the door to single-cell functional genomics applicable to any
organ.

Public health relevance
NARRATIVE A multi-lineage, transcriptional, and epigenetic understanding of alveologenesis and re-alveologenesis upon injury is a timely response to the burden of pulmonary diseases and leverages latest single-cell technology. The proposed project leverages our expertise in multiple lung cell lineages, single-cell genomics, mouse genetics, and bioinformatics; tackles fundamental questions of cell fate, plasticity, and signaling; relates to pulmonary diseases during development and upon injury; and opens the door to single-cell functional genomics applicable to any organ.